Mechanisms of Norovirus Pathogenesis and Replication to Develop Therapeutics

Mechanisms of Norovirus Pathogenesis and Replication to Develop Therapeutics
Project Summary
Noroviruses are the most common cause of gastroenteritis in the United States, and they cause a significant
economic and health burden to the population. A significant barrier to progress in making effective therapeutics,
antivirals and vaccines to control human norovirus illness was the previous lack of a cell culture system. The focus
of this program project is to build upon previous basic science and translational findings and discoveries to allow
continued progress in our understanding of the biology and pathogenesis of these viruses so that improved
control strategies can be developed. We recently developed a successful replication system that discovered strain-
specific requirements for replication and allows neutralization assays and antivirals to be tested. We will pursue key
questions on virus pathogenesis and cellular responses, structure-function studies on the interactions between
virus proteins and host components, discover key factors that restrict extensive propagation and test antivirals
and neutralizing antibodies in three separate projects. In Project 1 we will perform studies designed to provide
us with a fundamental molecular understanding of how human noroviruses cause disease, and of what epitopes
are recognized by human sera that are associated with virus neutralization, virus clearance, and protective
immunity. In addition, we will build on recent success and continue to develop antivirals for treatment and prevention
strategies that can be applied to at risk populations. In Project 2 we will continue to improve the cultivation system,
focusing on identifying the cell receptor(s) and understanding why all HuNoV strains do not grow in the replication
system. We will also evaluate molecular mechanisms by which norovirus replication regulates cellular innate
responses and whether these cellular responses regulate viral replication and spread. In Project 3 we will
determine the structural basis for novel functions of key proteins that regulate viral replication and virus-host
interactions to provide a rational framework for the development of antivirals. These projects will be supported
by three cores. Core A (Administrative Core) will provide centralized administrative and fiscal management
support and will coordinate programmatic activities. Core B (the Microscopy and Enteroid Core) will provide
expertise and services to each project related to electron microscopy and fluorescent microscopy. This core will
also maintain and provide enteroids, including genetically-modified cultures and biosensor lines to all projects.
Core C (the Protein and Small Molecule Chemistry Core) will provide all projects with access to purified proteins
and virus-like particles as well as facilitating site-directed mutagenesis activities needed. In addition, the Core will
synthesize small molecules to be used for protease and polymerase inhibition studies in each project. The program
project brings together a highly collaborative group of investigators with diverse skills and talents, and an
substantial history of working together. As in the previous funding period, the interactions among each project
and each of the cores will be extensive and synergistic such that the activities of each project will be enhanced
considerably over what could be accomplished if the projects were pursued independently.

Public health relevance
PROJECT NARRATIVE Human noroviruses are a leading cause of acute gastroenteritis. The proposed studies aim to improve our understanding of how these pathogens infect and replicate in intestinal cells, how virus proteins interact with the human host and how they cause disease symptoms. We will also understand how antibody responses protect from norovirus infections and develop drugs that can be used in the treatment of these infections.